COVID-19 - Vet-Lirn Network Capacity Building for SARS-CoV-2: -80 degree freezer andNanodrop

Project Abstract The University of Illinois (UI) Veterinary Diagnostic Laboratory (VDL) is a full service, AAVLD accredited, all species, reference laboratory. UI VDL is a member of the VET-LIRN. Since last April, UI VDL has tested over one thousand of samples for SARS-CoV-2 and more than one hundred of samples of large cats in four different zoos were tested positive. These positive and negative samples are important for SARS-CoV-2 clinical and research related activities. New freezer and Nanodrop will significantly increase our storage and testing capacity for routine case investigation and surveillance coordinated by Vet-LIRN.

Public health relevance
Public Health Relevance Statement: Project Narrative The purpose of this proposal is to get support to purchase a new -80 degree freezer and Nanodrop to increase sample storage and testing capacity for SARS-CoV-2, respectively, at UI VDL. This will provide enhanced capacity for FDA Vet-LIRN surveillance assignments and routine case investigation of SARS-CoV-2 in animals.